Caregiver-Child Communication Following Child Maltreatment: A Dynamic Systems Approach

PROJECT ABSTRACT
Child maltreatment (CM) is a significant public health concern that affects one million children annually, exerts
a societal cost of $2 trillion, and increases the risk for a range of adverse health outcomes. Difficulties in
emotion regulation (ER) is one potential pathway explaining how CM leads to a range of sustained adverse
health outcomes and empirical efforts to identify factors effecting ER, positively or negatively, have significant
potential to inform intervention strategies for children exposed to maltreatment. The Caregiver-Child (C-C)
relationship is critical to the development of ER abilities, but so far has not been thoroughly examined as a
potential mediator of the CM-ER relation in the CM population. Furthermore, no CM studies have used
observational methodology to examine dynamic, moment-to-moment C-C communication processes with older
children and adolescents. Such innovation and methodological rigor will elucidate real-time, bidirectional
processes during key developmental periods that can highlight specific targets for prevention and treatment
with the CM population. Leveraging observational data collected from a large, multi-wave, prospective NIH-
funded cohort study, The Child Health Study (P50HD089922), the present study will examine C-C
communication dynamics over three interactions focusing on C-C relationship enhancing and problem-solving
topics. The CHS affords richness in characterizations of CM via coding of official case files via the
Maltreatment Classification System, multi-informant assessment of caregiver and child health and socio-
emotional well-being, and an established C-C interactional paradigm. Caregiver validating and invalidating
behaviors during C-C interactions will be coded as well as child positive and negative affect. Importantly,
caregiver validating and invalidating behaviors have yet to be studied at more intensive time-scales (e.g., 30
second epochs) nor in direct relation to child positive and negative affect during C-C conversation, and thus the
present study has the potential to make a significant, innovative contribution to the CM literature. This
fellowship proposal will examine change and intra-individual variability in caregiver validating and invalidating
behaviors (Aim 1a) and child positive and negative affect over the course of three C-C interactions (Aim 1b),
as well as how caregiver validating and invalidating behaviors are longitudinally and bidirectionally related to
child positive and negative affect (Aim 2a). Hypothesized caregiver and child trait characteristics will also be
tested as moderators of these dyadic communication process (Aims 1c and 2b). Finally, C-C interaction
dynamics will be tested as mediators in the longitudinal relation between CM and ER (Aim 3), elucidating novel
behavioral targets for prevention and treatment in the CM population. Ultimately, successful prevention and
treatment efforts will reduce the personal and lifelong public health burden and societal cost attributable to CM.

Public health relevance
PROJECT NARRATIVE Child maltreatment is a prevalent public health concern associated with a plethora of negative long-term outcomes across childhood, adolescence, and into adulthood, including emotion regulation difficulties. Using observational methodology and dynamical systems analysis, the present study will research how moment-to- moment dynamics of caregiver-child communication, specifically: trajectories and intra-individual variability in 1) caregiver validating and invalidating behaviors (VIVBs), 2) child positive and negative affect, and 3) their bidirectional relationship to one another over the course of conversation, are related to child and adolescent emotion regulation ability. This research will highlight specific C-C communication dynamics that promote real- time positive or negative child affect and has the potential to establish VIVBs as targets for prevention and treatment, in turn promoting child and adolescent health for this high-risk group prior to the entry to adulthood.